New Projects

Project Summary/Abstract Funding is request in years 2 through 5 for new research projects, essentially replacing the initial three research projects once completed. These future research projects will undergo per review as described elsewhere in this application, and will require IAC and PSC approval.